Functional MRI Core Facility

Protocol number 93-M-0170, NCT00001360 Space Utilization: The Functional MRI Facility (FMRIF) currently occupies approximately 4800 sq. ft of space, divided between the scanner bays, control rooms and electronics/machine rooms for 3TA, 3TB, 3TC, 3TD, and 7T MRI scanners located within the NMR center and office space on the second floor above the NMR center in the FMRIF/SFIM suite (approximately 1400 sq ft total, including shared conference space). The FMRIF staff (currently 14 full- time positions) consists of: the facility director, four staff scientists to keep the scanners running, six MRI technologists, an information technology specialist, a programmer, and an administrative laboratory manger. The functional MRI facility supports the research of over 30 Principal Investigators translating to over 300 researchers overall. Over 70 research protocols are active and making use of FMRIF scanners. Each scanner has scheduled operating hours of 105 hours per week. Since its inception in 2000 until August 2017, a total of 1,126 peer-reviewed publications from intramural investigators have used data acquired in the FMRIF core facility. The total is distributed among 747 papers from NIMH, 280 papers from NINDS, and 99 from the other institutes. These papers have been cited a total of 106,561 times for a combined h-index of 161. In other words, 161 papers using the FMRIF have been cited at least 161 times. Projects: Projects: Staff Scientists working on projects are designated as: Sean Marrett (SM), Vinai Roopchansingh (VR), Andy Derbyshire (AD), and Linquing Li (LL). The goals of these projects are aimed to increase the overall utility of the fMRI core facility for the most possible users. Upgrade 3TA/B: SM and VR managed contracting, planning, design, construction and final equipping of upgraded 3TA/3TB suite and systems from HDx to mr750 platform including access to better chilled water. They also upgraded the visual stimulus system for 3TB. High resolution image recon: SM Continued collaboration with Laurentius Huber on high-resolution VASO/BOLD and TSNR optimized image reconstruction. New 7T host: SM acquired new 7T host to allow for more aggressive high-resolution scanning of humans on 7T with faster CPU and expanded storage. High resolution Simultaneous Multi-slice: SM established and validated routine high-resolution SMS imaging sequences on the 7T scanner (LBC/Baker,Grillon, Merriam) including routine whole brain 1.2mm3 and smaller field of view 0.9mm3 for imaging hippocampus and bed nucleus of stria terminalis Multi-modal integration: SM worked with Jen Evans and Peter Molfese on clarifying high density EEG acquisition procedures using EGI system. Automated Quality control: SM is currently implementing an automated MRI quality control system and automated BIDS data conversion software package (being tested by Jan Verada)in collaboration with data sharing team. Eye Tracking: SN us Acquiring/validating new high quality eye tracking systems for 3TA, 7T, and 3TD. Distortion correction testing: VR is working with Sue Swedo on testing distortion correction techniques on EPI and structural images. Real time EPI software: VR is developing real-time display and feedback software that runs on the FMRIF scanners. Most recently, these have been used for neuro-feedback experiments in a study of an autistic population by Alex Martins group in NIMH. There are upcoming potential collaboration using this capability, both from NHGRI (Philip Shaw) and NIAAA (Reza Momenan). Gadgetron: VR has continued his involvement with the ISMRMRD and Gadgetron projects. Over the last year, he has openly made available (in a public GitHub repository) a template ISMRMRD converter that converts data from General Electric scanners into the ISMRMRD format. He will continue his involvement to leverage the advantage the Gadgetron and ISMRMRD hold for the plethora of platforms the FMRIF currently supports. Blood nulling implementation: LL is working on implementing a method by which intravascular spins travelling at velocities above 2-3 mm/sec are nulled. The sequence that performs this nulling is called a DANTE-EPI sequence. The goal is to increase localization of fMRI by eliminating downstream vessels. Dynamic Phase Correction: AD has implemented dynamic phase correction for multi-echo EPI. EPI-based T1 mapping: AD has developed a variable flip-angle multi-echo EPI sequence to simultaneously measure the BOLD signal and the T1 map using multi-echo EPI-based fMRI sequence. A modified multi-echo EPI sequence is used for quantitative measurement of fMRI signal. LL has established a standard, non-EPI, approach to T1 mapping using Inversion recovery prepared Turbo spin echo (TSE). Head Gradient Coil: AD and VR have been examining the performance and impact of a local head gradient coil for the FMRIF scanner systems. Cross scanner comparison work: AD is developing common pulse sequence components to develop standardized (to the limits of the MR hardware) pulse sequences across various MRI platforms. This is analogous to the complementary efforts to employ vendor independent reconstructions. 3D-EPI support: AD is Supporting development of a 3D-EPI sequence by Daniel Reichs group for high resolution susceptibility weighted imaging for the detection of MS plaques with a central vein. This work involves maintaining pulse sequences for sites in their multi-center initiative, as well as improving the existing sequence -- e.g., adding multi-dimensional acceleration and motion correction. Motion correction: AD is Assisting with their efforts to use the Kineticor motion correction system in combination with Dr. Talagalas pCASL-EPI perfusion sequence.